Development of an emulsion-based method for repertoire-scale paired-chain T cell receptor sequencing

Project Abstract
T cell recognition of peptide-Major Histocompatibility Complexes is a key determinant of response to infection,
cancer, and autoimmunity. While there have been recent technological advances that have enabled better
tracking and analysis of the T cell receptor repertoire, these approaches are extremely resource intensive and/or
have key technical limitations. Here, we propose a novel method that combines emulsion-based partitioning and
computational sequence deconvolution to enable large-scale determination of the naive T cell repertoire at
modest cost (estimated to be ~$1/3,000 cells at current reagent and sequencing costs, as compared to the
~$1/cell for current techniques). We will first develop and validate the experimental modifications to establish
this technique, including development of low-cost DNA barcoding beads, formation of cell/bead emulsions, and
efficient conversion and capture of TCR transcripts. We will then extend our previous computational approach
to deconvolute pools of TCRα/TCRβ sequences, and validate our method on T cells obtained from healthy
donors. In addition, we will extend our methodology to include oligonucleotide tagged pMHC multimers, enabling
repertoire-scale tracking of TCRα/TCRβ-pMHC pairings. Together, these technologies will enable efforts to track
the T cell repertoire at extremely large scale, an advance necessary for both mechanistic immunology and
computational prediction of antigen reactivity.

Public health relevance
Project Narrative T cells are key mediators of immunity in cancer, infection, and autoimmunity. Better enumerating the sequences that comprise human T cell receptor repertoires will aid our understanding of immune function and dysfunction. Here, we propose a novel approach that enables low-cost, repertoire-scale study of T cells.